[RNW] - Gamete Interactions in Caenorhabditis elegans

RELEVANCE: Fertilization is biological process with important medical, social
and economic implications. From extensive study, the events of fertilization are known in
some detail. However, the molecular underpinnings of these events generally remain
elusive. Most previous work on fertilization has relied on biochemical and immunological
approaches. Our work is groundbreaking in the application of classic gentic analsysis to
this vital area of research.
RATIONALE: Many of the genetic and molecular tools developed for C. elegans
are not available or are very difficult to utilize in other organisms traditionally used for
studying fertilization. One of the most significant advantages of C. elegans is the ability
to isolate and maintain mutants that affect sperm or eggs and no other cells. Previously,
through the study of sterile mutants, we have identified some of the first molecules
required for productive gamete interactions in C. elegans. We aim to get a better
understanding how sperm molecules (SPE-13, SPE-36, and SPE-51) function to insure
successful fertilization. The Izumo-like spe-45 and spe-51 genes represent conserved
sperm function from worms to humans. Futher, a full understanding of the molecular
mechanisms of fertilization is impossible without a more complete inventory of molecular
components. Therefore we aim to identify new fertilization molecules through genetic
and molecular analysis. Particular emphasis will be placed on the identification of genes
required in oocytes.
OBJECTIVES: The goal of this proposal is to further our understanding of
fertilization in C. elegans by conducting the following experimental aims: 1) Investigate
mechanistic connections, functions, and fertilization pathways of the gamete function
molecules SPE-13, SPE-36, and SPE-51. 2) Conduct complementary forward and
reverse genetic screens for fertilization mutants. We will take advantage of an innovative
genetic screening strategy that enriches for gamete function mutants. 3) Determine the
molecular nature of new gamete function genes defined by a fertilization defective
mutant phenotype. This work will complement fertility studies in other organisms as well
as provide insights into the mechanisms of cell-cell interactions and the diversity of
reproductive strategies.

Public health relevance
Although the cellular events of fertilization are fairly well described, the molecular underpinnings and genetic pathways that regulate the process are not well understood. We are identifying genes and molecular mechanisms of fertilization in the Caenorhabditis elegans model system. This work complements studies of fertilization in other species and could lead to a better understanding of the causes of infertility, the diversity of reproductive strategies, and the design of new contraceptives.